MAINTENANCE OF NIAID SPECIFIC PATHOGEN-FREE MACAQUE BREEDING COLONIES

The objective of this contract is to continue to maintain a government owned non-human primate (NHP) breeding colonies of Indian-origin rhesus macaques and Mauritian cynomolgus macaques and supply healthy, specific-pathogen free macaques for biomedical research to support research conducted by the NHP Primate Transplantation Tolerance Cooperative Study Group.